Organizing Principles of the Neural Circuits for Social Interaction

1 PROJECT SUMMARY
2 Cooperation and reciprocation are a hallmark of human behavior and key for creating and maintaining
3 social bonds. Yet despite their importance to both normal and abnormal social function, little is known
4 regarding their single neuronal and population underpinnings.
5 We propose to study, for the first time, how representations of recent social experience are formed
6 and maintained, then retrieved and updated with the goal of elucidating how these ultimately guide social
7 cooperative behavior. We will quantify cooperation using rhesus macaques playing the well-studied
8 iterated Prisoner’s dilemma game (iPD). In iPD, players can repeatedly cooperate for the common good
9 or exploit the other for their own benefit, and change their choices based on the other’s preceding move.
10 Using this approach, we previously described a neuronal circuit in the dorsal Anterior Cingulate Cortex
11 (dACC) where subsets of neural populations encode cooperative decisions and expected reward of other
12 individuals, distinct from neurons encoding one’s own decisions and reward.
13 Here, we build on these findings to investigate how the brain integrates recent interactions to support
14 cooperation. We will use large-scale simultaneous recordings in the primate Prefrontal Cortex to study
15 representations of one’s own and others’ actions, to delineate the functional neural architecture that
16 allow dynamic responses in ever-changing social contexts, and to study inter-brain neural synchrony
17 between monkeys cooperating while playing iPD. Such understanding is crucial for parsing how social
18 behavior falls apart in an array of neurological and psychiatric disorders and for devising future targeted
19 treatment of debilitating social disorders.

Public health relevance
Disorders such as major depression, schizophrenia, and autism spectrum disorders are marked by debilitating deficits in social interactions, but our lack of understanding of the basis of social interactions presents a major roadblock to developing neural circuit-based therapies to treat them. Here, we propose to study the single-neuron and circuit basis of cooperation and inter- brain synchronization using rhesus macaques playing cooperative social games. We will investigate how recent social interactions shape neural representations and the causal basis of cooperation.